Project 1: Preservation of Peripheral Function and Structure

PROJECT 1: PROJECT SUMMARY/ABSTRACT
In cochlear implant (CI) users, mechanisms underlying difficulties in understanding speech in complex
listening environments remain poorly understood, which hinders our capabilities of implementing precision
medicine in this patient population. In this study, we will take a bottom-up approach to identify neurophysiological
mechanisms underlying speech perception deficits in CI users. Our central hypothesis is that preservation of the
structural and functional integrity of the peripheral auditory system will result in improved clinical outcomes,
especially in challenging listening conditions. Surgical trauma of cochlear implantation and the foreign body
reaction to CI electrode array cause inflammatory response, which reduces the structural and functional integrity
of the peripheral auditory system. There are two newly developed strategies for minimizing surgical trauma and
immunological response to CI electrode: steroid-eluting electrode array and robotics-assisted electrode insertion.
To date, the functional benefits of using these two novel strategies in preserving the functional and structural
integrity of the peripheral auditory system in human CI users have not been established. To address this critical
need, Aim 1 and Aim 2 will determine the effect of steroid-eluting electrode arrays and robotic-assisted electrode
insertion on structural and functional integrity of the peripheral auditory system in human CI users, respectively.
Another factor which affects the structural and functional integrity of the peripheral auditory system is genetic
variation. To date, the effect of genetic variation on the ability of the peripheral auditory system to respond to
acoustic and electrical stimulation in human listeners remains poorly understood. To address this critical need,
Aim 3 will determine the effect of genetic variation on the ability of the CN to respond to acoustic and electrical
stimulation. Results of this study have high scientific significance because they will establish 1) the benefits of
using steroid-eluting electrode array and robotics-assisted electrode insertion preserving structural and
functional integrity of the peripheral auditory system, and 2) the effects of genetic variation on the ability of the
peripheral auditory system to respond to acoustic and electrical stimulation in human CI users. Results of this
study also have high clinical significance because they will 1) serve as the scientific foundation for shifting the
current clinical practice for CI patients by including steroid-eluting electrode array or robotics-assisted electrode
insertion as part of standard clinical care, and 2) lay the groundwork for developing effective, evidence-based
clinical practice guidelines for managing CI patients based on genetic data.

Public health relevance
PROJECT 1: PROJECT NARRATIVE The proposed study is relevant to public health because it aims 1) to determine functional benefits of two techniques of reducing intracochlear trauma caused by cochlear implant surgery, and 2) to better understand the relationship between genetic variations and peripheral auditory function. Results from this study will have a broad impact on the field by 1) providing the scientific foundation for shifting the current clinical practice for cochlear implant patients by implementing Dex-eluting electrode array or robotics-assisted electrode insertion as part of standard clinical care, and 2) laying the groundwork for developing effective, evidence-based clinical practice guidelines for managing cochlear implant patients based on their genetic etiologies. This project is relevant to the mission of NIH because it seeks fundamental knowledge about the nature of electrical hearing and strives to apply this knowledge to reduce disability in patients with cochlear implants.